Use of accelerometry data for patterns of daily activity in older persons

Accelerometry data from the National Health and Nutrition Examination Study (NHANES) confirms what has been suspected from self-report: after adolescence, people in the United States are very inactive. With age, even this modest activity declines further. To better explore the association of physical activity and inactivity with conditions and outcomes of aging, accelerometry data has been collected on participants from the Health, Aging, and Body Composition study, Age, Gene/Environment Susceptibility Study in Iceland, Women's Health Study, Regions for Geographic Differences in Stroke, and a trial of rehabilitation therapy in older acute heart failure patients (REHAB-HF). Also, as part of this project, we compare measurements and physical activity patterns derived from accelerometers worn at various locations on the body while eldery participants conduct activities of daily living. These projects include research questionis surrounding physical activity monitoring among clincal research patients and major life events, such as retirement.